Biochemistry, Cellular and Molecular Biology Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Biochemistry, Cellular and Molecular Biology (BCMB) Graduate Program has trained more than 700 scientists since 1972. BCMB serves as the major training program for seven basic science departments at the Johns Hopkins University School of Medicine and is one of the oldest multidisciplinary graduate programs in the country. There are 100 faculty members actively involved in research, teaching and as mentors. The Departments that participate in the program are Biological Chemistry, Biophysics and Biophysical Chemistry, Cell Biology, Molecular Biology and Genetics, Neuroscience, Pharmacology and Molecular Sciences, and Physiology. An average of 22 students matriculates each year and obtain their Ph.D. in an average of 5.7 years. The objectives of the BCMB program are: (1) to provide a broad and deep science curriculum; (2) to provide longitudinal training in rigorous, reproducible and responsible experimental research;
(3) to provide training in professional skills; (4) to provide activities for trainees to explore career options; and (5) to recruit and support students into a rigorous training environment that is positive, supportive, and safe. These objectives will be met through a rigorous curriculum covering the first year of study that includes courses focused on macromolecules (energetics, structure and function), molecular biology and genomics, genetics, organic mechanisms in biology, cell structure and dynamics, and pathways and regulation. There is a new strong emphasis on bioinformatics and computational skills throughout the coursework. There are multiple paper discussion courses extending from years 1 through 3 to support training in rigorous and reproducible research. There are discussion courses that focus on responsible conduct of research, in addition to department-based workshops as students advance in their thesis work. Oral and written presentation skills are developed throughout training through workshops targeting different specific tasks (oral exams, chalk talks, manuscript and proposal writing). Professional development and career planning is an integral part of the program, occurring through workshops and courses throughout the training period, as well as diverse internship offerings. Most students publish multiple research papers and the training concludes with presentation of a public seminar and submission of the doctoral thesis. BCMB graduates hold leadership positions at all levels of academia, government and industry. The success of our students is fostered by an extraordinary level of collaboration and interaction among the faculty and trainees. Special emphasis is placed on applying conceptual breakthroughs in basic science to problems relevant to human health and disease. Here we request 25 training grant slots to appoint training grant eligible students during their first two years in the program.

Public health relevance
PROJECT NARRATIVE The purpose of the Biochemistry, Cellular and Molecular Biology Graduate Program is to train outstanding scientists for diverse careers in biomedical research. This goal is achieved through a rigorous, broad-based curriculum and independent research in a basic science laboratory. This type of training is essential for understanding human disease at a fundamental level, and allows our students to enter the biomedical workforce where they contribute to breakthroughs in biology and medicine.